Research Capacity Core

Research Capacity Core
Summary
The primary goal of this core is to create infrastructure to support
investigators in our IHER Center. Over the past decade and a half, DSU has
expanded its faculty in biomedical- and health-related areas and has grown its
research infrastructure. In order to sustain and grow our research enterprise in this
time of hyper-competition for funding, DSU must support its current faculty to develop outstanding
research programs. Quality research infrastructure and access to research resources are absolutely crucial
for developing our institutional research and research training capacity. The Research Capacity Core of our
IHER Center will strengthen DSU’s infrastructure for biomedical, social and behavioral research related to
health disparities and health equity.
This Core will provide support for qualitative research and program evaluation for DSU
investigators, and will support existing cores in microscopy and cell electrophysiology that provide crucial
resources to biomedical researcher and pilot projects. It will also provide research design, epidemiology
and biostatistics support for health equity researchers, primarily through partnership with the Biostatistics,
Epidemiology, Research Design (BERD) Core of the NIH-funded Delaware Clinical & Translational
Research Center (ACCEL), in which DSU is a partner. The BERD Core provides consultative services in
the areas of epidemiology, biostatistics, research design, data management, and bio- and medical
informatics, and the services vary from assistance analyzing existing datasets to developing collaborative
complex data management strategies and protocols that inform grant or IRB submissions. Consultation and
collaboration emphasize developing engagement with the clinical research community, as well as
community partners.
The Research Infrastructure Core will also support development of new research resources at DSU
and strengthen what is currently available. First, we will develop a Qualitative Research & Evaluation
Resource to assist behavioral and social researchers at DSU incorporate qualitative methods into their
research to gain a deeper understanding of the “why” and “how” of people’s experiences and perceptions.
It will also support RCMI research and pilot projects with software tools for behavioral and population
research such as GIS, NVivo, Dedoose, ATLAS.ti, SSPS and data security expertise for human subjects
data and to support joining the REDCap consortium. Responsive to the RCMI mechanism our IHER Center
supports basic biomedical research as well as behavioral and social research related to health equity. Our
core will strengthen existing core facilities in bioimaging and cell electrophysiology to enhance the quality
and productivity of biomedical research projects supported by the Center.